Mechanism and rescue of lysosomal defects in Adult-onset Neuronal Ceroid Lipofuscinosis

PROJECT SUMMARY
Adult-onset neuronal ceroid lipofuscinosis (ANCL) is a fatal lysosomal storage disorder known to be caused by
autosomal dominant mutations (CSPαL115R, CSPαL116del) in the gene encoding cysteine string protein-alpha
(CSPα). There are currently no treatments that can reverse or slow ANCL progression, which leads to progres-
sive cognitive and motor impairment, epileptic seizures, dementia, and premature death. CSPα has no estab-
lished connection to lysosomal function and is known to form a chaperone complex with SGT (small glutamine-
rich tetratricopeptide repeat-containing protein) and Hsp70/Hsc70 (heat shock protein/cognate protein 70 kDa),
which chaperones the synaptic SNARE protein SNAP-25. My preliminary data establishes SNAP-23, a homo-
log of SNAP-25, as a previously unknown client of the CSPα/SGT/Hsc70 chaperone complex. This interaction
was found via (i) immunoprecipitation of CSPα from wild type mouse brain followed by tandem mass spectrom-
etry identification of SNAP-23, (ii) reduced SNAP-23 protein levels in CSPα knockout (CSPα-/-) mouse brains,
and (iii) co-immunoprecipitation of SNAP-23 with each member of the CSPα/SGT/Hsc70 chaperone complex.
Importantly, SNAP-23 forms a SNARE-complex with VAMP7 and syntaxin-4, the formation of which mediates
Ca2+-dependent lysosomal exocytosis. Accordingly, I found diminished Ca2+-dependent lysosomal exocytosis
in CSPα-/- primary neurons by measuring cell surface exposure of the LAMP-1 luminal domain. This preliminary
data provides a novel, direct link between ANCL mutations in CSPα and the lysosomal pathology observed in
ANCL, via impaired SNAP-23 function. The proposed study aims to (a) delineate the specific molecular mecha-
nism(s) by which CSPα mutations impair SNAP-23 function, leading to the lysosomal pathology of ANCL, and
(b) to evaluate the lysosomal SNARE-protein SNAP-23, a novel client of the CSPα/SGT/Hsc70 chaperone
complex, as a potential therapeutic target for ANCL. I hypothesize that ANCL-causing mutations CSPαL115R
and CSPαL116del reduce the ability of the CSPα/SGT/Hsc70 complex to effectively chaperone lysosomal
SNARE protein SNAP-23, leading to defects in SNARE-complex assembly and lysosomal exocytosis
which can be rescued by increasing SNAP-23 protein levels. In this proposal, aim 1 will examine how
ANCL-causing mutations in CSPα impact the ability of the CSPα/SGT/Hsc70 complex to chaperone SNAP-23,
and how loss of CSPα chaperone activity impacts SNAP-23 stability, lysosomal SNARE-complex assembly,
and lysosomal exocytosis. Aim 2 will evaluate the potential of genetic and pharmacological strategies that in-
crease SNAP-23 protein levels to rescue (a) SNARE-complex and lysosomal defects resulting in primary neu-
rons from CSPα-/- mice and (b) premature lipofuscinosis and neurodegeneration in CSPα-/- mice. Successful
completion of these studies will inform the development of rational therapeutic strategies for ANCL patients.

Public health relevance
PROJECT NARRATIVE Despite having an established genetic cause, no effective treatments exist for the fatal, neurodegenerative lysosomal storage disorder Adult-onset Neuronal Ceroid Lipofuscinosis (ANCL). The objective of this study is to delineate the precise molecular mechanisms underlying ANCL pathogenesis. Completion of these studies will inform the development of rational therapeutic strategies for patients with ANCL.